Vascular Proliferative Resilience

SUMMARY
In adults, the generation of new blood vessels is confined to capillaries, where it facilitates tissue growth,
remodeling and repair. De novo expansion of the microvascular network occurs through active proliferation and
migration of endothelial cells. In contrast, endothelial proliferation in adult large blood vessels, such as arteries,
is thought to be rare, except for responses to trauma. We have shown that endothelial injury following physical
trauma to the aorta triggers a rapid proliferative response leading to the prompt repair of the inner vascular lining,
known as the endothelium.
Our preliminary findings indicate that, in addition to physical trauma, chronic inflammation can lead to the
demise of endothelial cells in large vessels. We further found that endothelial cell death was associated with a
concurrent induction of proliferation, providing a balance between cell loss and renewal that ensures continuity
of the endothelial barrier. However, this proliferative response is impaired in aging, creating a deficit in endothelial
coverage that results in the deposition of fibrin. These results suggest a previously unrecognized deterioration
in the ability of large vessels to maintain adequate regulation of vascular integrity and reveal an unmet need in
cardiovascular biology. To this end, we propose experiments to decipher the dynamics, spatial context, and
molecular regulators of proliferation in the endothelial lining of the aorta.
We used a novel mouse model that precisely titers arterial endothelial cell death. Using this model, we found
that proliferation quickly compensates for the lost cells and highlights the important role of endothelial cell
proliferation to restore such deficits. The findings also uncovered a remarkable proliferative capacity in the aorta
that was previously unrecognized. Importantly, pharmacological blockade of this proliferative activity resulted in
organismal death. The findings support the novel concept that ongoing proliferative repair of large vessel
endothelial cells is an essential and previously unsuspected biological function. These data prompted several
questions: What is the proliferative capacity of aortic endothelial cells? What stressors mediate cell death in the
aortic endothelium? Is the reserve proliferative capacity of the endothelium impacted by metabolic alterations
associated with common comorbidities (hyperlipidemia, diabetes) or oxygen-reperfusion events?
Energized by these questions and our robust preliminary data, we hypothesize that Endothelial cells of the
aorta retain a significant proliferative reserve that is continuously available for repair. This capacity is restrained
by metabolic comorbidities that limit vascular resilience and cell-cycle entry. Two aims were developed to test
this hypothesis: (1) To characterize the proliferative reserve of endothelial cells in the aorta. and (2) To determine
whether metabolic comorbidities impact aortic endothelial proliferative resilience. These broadly defined aims
have been conceptualized to fill gaps in our knowledge of fundamental processes in endothelial cell biology and
to exploit this information for mechanistic studies and medical applications.

Public health relevance
NARRATIVE This research aims to characterize and mechanistically explore the proliferative capacity of large artery endothelial cells exposed to metabolic stress. The information obtained from these studies is poised to identify targets for future therapeutic exploration. This research is directly relevant to the NIH mission: to reduce illness and disability.